Administrative Core

ADMINISTRATIVE CORE: SUMMARY
The Northwestern Brain Tumor SPORE Administrative Core will provide structure and organization to this
program of research, and will function under the direction of Drs. Lesniak (PI) and James (Co-PI), with input
from the SPORE Executive Committee, and with guidance from the Internal and External Advisory Boards. The
core leaders are accomplished brain tumor researchers, and are experts in tumor biology, experimental
therapeutics, and preclinical as well as clinical studies. As such they are well qualified to supervise this
SPORE, and see to its productivity as well as impact on treatment outcomes for brain tumor patients. Based on
committee and advisory board recommendations, the Core Directors will make final decisions on any issues
that involve the timely progression of the SPORE. Further, as core directors they will have overall scientific and
financial responsibility for this SPORE. They will disburse funds and will receive regular accounting of the
financial status of each project. Staff support for the Core will be provided by Lurie Cancer Center (LCC)
Administrator Dr. Robin Leikin, Grants and Contracts Administrator Mr. Daniel Rademacher,
Program/Advocacy Administrator Ms. Angela Park, and patient advocate Dr. Paul Lukac. Through the efforts of
these individuals and activities of the Administrative Core, mechanisms will be in place and procedures applied
for enabling high quality, team-oriented, and productive investigations.

Public health relevance
ADMINISTRATIVE CORE: NARRATIVE SPOREs are multi-faceted and complex research programs with many “moving parts”. The Administrative Core will provide structure and organization to ensure integration and to see that synergy is achieved as a result of interactions between the many parts of this SPORE, and by facilitating Northwestern Brain Tumor SPORE interactions with other NCI-supported programs of research.